An artery-on-a-chip system containing blood outgrowth endothelium as a model of vaso-occlusion and drug testing in sickle cell disease

An artery-on-a-chip system containing blood outgrowth endothelium as a model of vaso-occlusion and drug testing in sickle cell disease Challenge: Sickle cell disease (SCD) is a vascular and hematological disorder in which there is a fundamental gap in the understanding of: 1) how organ-level signaling occurs in arterial blood vessels and why it varies from patient to patient, and 2) how cells inside the vascular organ contribute to vaso-occlusions. The persistence of this problem is partly due to the fact that animal models do not represent SCD faithfully, and as a result cannot predict the responses to drugs relevant to humans. Recent advances in organ-on-a-chip technology have permitted co-culture of human cells in physiologically-relevant microfluidic environments and also allowed whole blood perfusion, providing an alternative in vitro approach to mimic the human disease. These microsystems however, still have not reached their full potential due to variability of generic cell lines used, and absence of efficient and scalable primary human patient cells. To meet these complex challenges, the applicant’s goal here is to develop a new class of microphysiological system that contain all autologous vascular and blood cells easily drawn from blood samples of the same human subject. Proposal: The objective is to design and establish the feasibility of an artery-on-a-chip system that contains culture of autologous human blood outgrowth endothelial cells (BOECs), permits the perfusion of whole blood of the same patient and provides dynamic cellular and molecular readouts that help dissect SCD pathophysiology and drugs. The research proposed is innovative, because it contributes in shifting the focus of modeling vascular pathophysiology from animal models to using organ-on-a-chip platform containing only autologous cells. Here, the central hypothesis is that in the presence of BOECs of SCD patients, the same patient’s blood cells and platelets will adhere more rapidly to the endothelium when compared to generic cell lines. Secondly, treatment of BOECs with hydroxyurea may inhibit such platelet-endothelium interactions, depending upon the patient’s history of stroke. Guided by the applicant’s recent publications and collaboration with an expert in biology and hematology, two specific aims will be pursued: 1) demonstrate an artery-on-a-chip with BOECs and 2) determine tissue-specific effects of hydroxyurea treatment in SCD occlusion. Outcomes: Under Aim #1, this new platform will enable blood to be perfused through the vascular channel of the same patient. This system will also allow precise measurements of cell adhesion, cytokines and vaso-occlusion. Under Aim #2, the treatment of this autologous SCD artery-on-a-chip with hydroxyurea will provide insight into its specific therapeutic effects on the patient endothelium and blood cells. It will also inform dosing requirements in patients who had a prior stroke vs who did not. Significance: The outcomes will lead to further applications of the organ-on-a-chip technology using BOECs as a functional and scalable cell source to study vascular dysfunction and thrombosis in SCD and other cardiovascular diseases.

Public health relevance
Project Narrative This research is relevant to public health because the development of this functional organ-on-a-chip technology of sickle cell disease is ultimately expected to increase the understanding of the biology of vascular malfunction and stroke in patients, as well as predict the response to drug candidates to the extent that it motivates new and effective clinical trials. Since this will be the first instance that the proposed methodology will contain all living cells that are obtained from the blood samples of the same patient, this is most relevant to the NIBIB Trailblazer Award criteria that pertains to developing novel approaches to address unmet biomedical research needs.